An upgrade of the area detector for the FMX beamline at NSLS-II

Project Summary/Abstract
We propose to upgrade the X-ray area detector of the Frontier Microfocusing Macromolecular Crystallography
(FMX) beamline at the National Synchrotron Light Source-II (NSLS-II). The current detector, a DECTRIS Eiger
X 16M will reach its end of support in 2025. We propose to upgrade it with an Eiger2 XE 9M detector with a
450 µm Silicon sensor.
The new detector will ensure the beamline’s highly reliable operation for the US structural biology and
biomedical user community. The five to ten times higher frame rate, and the three times higher count rate will
enable users to align and interrogate crystals with higher resolution diffraction-based raster maps to collect
higher resolution and higher fidelity data from smallest crystals and from inhomogeneous and hard to align
crystals. The higher frame rate will increase the productivity of the measurements by allowing users to collect
data from more crystals, for more efficient screening for best diffracting crystals, for sampling a larger
parameter space in ligand screening and fragment screening measurement campaigns for drug research. The
ability to collect frames faster and with a finer step size will allow the development of optimized and more
automated workflows, for example for multi-crystal data collection to merge data from multiple marginal
crystals, which previously may have required a time-consuming crystal optimization back in the researchers’
home laboratory. Location of smallest microcrystals with the smallest beam focus of 1 micrometer of the FMX
beamline will allow collection of complete datasets from crystals that are intractable at other US beamlines.
The Si sensor will enable data collection at longer wavelength to support the identification of functionally
important ions and metals, for example in enzyme active sites. New triggering and gating modes will increase
accessible time scales in dynamic and time-resolved crystallography.
In summary, the new detector will ensure the beamline’s reliability, and will allow NIH-funded investigators and
other researchers to collect more high-quality data faster, to support their scientific discovery.

Public health relevance
Project Narrative By unraveling the three-dimensional structure of biomacromolecules, from single molecules, molecular complexes, or molecules with bound ligands, structural biologists can determine their function, and study their biological role, for example to design improved versions of enzymes, or find drugs to alter their function. The Frontier Microfocusing Macromolecular Crystallography (FMX) beamline at the National Synchrotron Light Source-II (NSLS-II) at Brookhaven National Laboratory is a premier resource for US researchers to determine these structures using macromolecular crystallography with the smallest microfocus beam available in the US. By upgrading its current aging X-ray detector with a new state of the art model, FMX will be able to retain its role as a leading resource for supporting structural biology and biomedical research.